Regulation of tumor associated macrophage function by STAT5 in breast cancer

PROJECT SUMMARY
Breast cancer growth and progression require complex interactions between tumor cells and their
surrounding environment. Increased numbers of infiltrating inflammatory cells, in particular macrophages,
correlate with poor patient prognosis in breast cancer. Our studies have focused on identifying key signaling
pathways within macrophages that drive their functions within the tumor microenvironment, including those
that drive anti-tumor macrophage phenotypes. Specifically, we have found that treatment of macrophages
with the cytokine granulocyte macrophage colony-stimulating factor (GM-CSF) drives an immunostimulatory
expression profile in macrophages that is dependent upon signal transducer and activator of transcription 5
(STAT5). Furthermore, using conditional genetic knock-out approaches, we have found that loss of STAT5
signaling in macrophages leads to enhanced mammary tumor progression. This proposal focuses on further
understanding the impact of STAT5 signaling in tumor associated macrophages and determining whether
modulating STAT5 in macrophages impacts breast cancer growth and progression. Based on our preliminary
results, we hypothesize that loss of STAT5 in macrophages promotes an immunosuppressive environment
that enhances mammary tumor growth and metastasis and that restoration of STAT5 activity in
macrophages will enhance anti-tumor immune responses, leading to decreased tumor growth and
metastasis. Studies proposed in Specific Aim 1 will use genetic mouse models to define the effects of myeloid
STAT5 deletion on mammary tumor growth and metastasis and determine the requirement for GM-CSF for
STAT5 activation in tumor associated macrophages. Studies proposed in Specific Aim 2 will define the
mechanisms through which modulation of STAT5 in myeloid cells impacts tumor progression by identifying
direct STAT5 target genes in macrophages and assessing the roles of STAT5-regulated chemokines to
modulation of the immune environment. Studies in Specific Aim 3 will develop new antibody-based
approaches to determine the impact of restoring STAT5 function in macrophages on tumor growth and
metastasis and use multiplex imaging to define the cellular neighborhoods associated with STAT5-activated
macrophages in human breast cancer samples. The focus of these studies is to examine the impact of
modulating the STAT5 pathway selectively in macrophages with a goal of enhancing anti-tumor immune
responses. Obtaining a better understanding of the mechanisms through which macrophages impact tumor
progression and respond to cancer therapies will ultimately lead to the development of approaches that
exploit their potential anti-tumorigenic properties for therapeutic purposes.

Public health relevance
PROJECT NARRATIVE The proposed studies focus on understanding the mechanisms through which specific signaling pathways regulate macrophage function during breast cancer initiation and growth. This research is relevant to human health because understanding the mechanisms driving tumor cell-stromal interactions during the growth and metastasis of human breast cancers will ultimately lead to the development of novel therapeutic strategies that will improve patient outcome by enhancing initial response, preventing resistance and reducing relapse.